Mitigation of Ionizing Irradiation-Induced Intestinal Damage by Second-Generation Probiotic LR-IFN-β

Abstract
We have developed a genetically modified second-generation probiotic for the localized delivery of a known
mitigator to the GI tract in order to reduce damage and regenerate tissue after exposure to ionizing radiation.
Mitigating the effects of ionizing radiation exposure is critical for improving survival in the event of a radiological
or nuclear (RAD-NUC) incident, where exposure could lead to hematopoietic or gastrointestinal (GI) acute
radiation syndrome (ARS). While Neupogen and Neulasta have been granted label extensions by the FDA to
treat casualties of a RAD-NUC incident, these drugs do not prevent GI-ARS-related mortality. There currently
are no FDA-approved mitigators for GI-ARS. To address this critical need, we have engineered
Limosilactobacillus reuteri to produce the therapeutic cytokine INF-β and target the mitigator to the small
intestines to recover intestinal stem cells, regenerate the radiation-sensitive intestinal crypts, and dramatically
improve survival from 0–10% to 70–80% after exposure to GI-ARS-inducing radiation doses. This is a new
strategy for therapeutic drug delivery, using a probiotic that can be administered orally, facilitating its
use in the context of a resource-limited mass casualty scenario. In addition to mitigating injury following a
RAD-NUC incident, this approach is also applicable to radioprotection of the intestine during abdominal
radiotherapy. Symptoms of GI toxicity affect 60–80% of the >300,000 patients that receive pelvic or
abdominal radiation therapy per year. This project is based on an entirely new concept that addresses the
fundamental major limitations associated with delivery of any potential radiation mitigator of GI syndrome,
including (i) non-invasive administration, (ii) targeted delivery of the therapeutic, (iii) maintained
bioavailability of the therapeutic at efficacious dose, (iv) trivially scalable to produce, and (v) no need for
formulation. The goal of this project is to develop an FDA-approved mitigator for radiation-induced GI injury.
We propose critical studies to characterize the radiation dose response, establish the pharmacodynamics of the
drug, and characterize the mechanism of drug release in the intestine. These studies are in response to FDA
feedback and are aligned with drug approval under the Animal Rule. Successful completion of this work will
place this probiotic drug on a strong path towards eventual FDA approval.

Public health relevance
Project Narrative Mitigating normal tissue toxicity after exposure to ionizing radiation is critical to reduce mortality and morbidity, both for patients that receive pelvic or abdominal radiation therapy, and in the context of a RAD-NUC incident. We have developed second-generation probiotics engineered to express the therapeutic cytokine INF-β that has been shown to increase survival from 0–10% to 70–80%. The goal of this project is to perform key small animal radiation dose response, pharmacodynamic, and drug characterization studies aligned with regulatory approval under the Animal Rule. If successful, this drug development effort will lead to the only FDA-approved radiation mitigator for GI toxicity.